A novel rat sperm cryopreservation and artificial insemination system

Summary
ParaTechs Corporation aims to provide researchers with advanced technology and methods to simplify
procedures for laboratory animal models. This proposal is a direct response to PAR-21-225; Novel Tools and
Devices for Animal Research Facilities and to Support the Care of Animal Models. The goal is to improve
vivarium management through cryopreservation, strategic breeding, and organizational approaches currently
unavailable for rats. The rat artificial insemination system (RAIS) is a complete rat sperm cryorecovery system.
This system will revolutionize cryopreservation practices and vivarium management for rat models. First, sperm
is cryopreserved in a “Cryodropper” device, which will quickly and easily freeze rat sperm. Second, sperm is
recovered in a novel motility enhancing device (MED) which selects for motile sperm, removes cryoprotectants,
and concentrates the sperm sample. The third part of the system is a novel device, which is used to transfer
concentrated motile sperm to the uterine horn of recipient female rats. This non-surgical insemination device
(NSID) provides a non-surgical alternative to traditional surgical artificial insemination and requires no anesthesia
or analgesia. Each innovative part of the system provides a critical function for rat cryorecovery and together
provide a cohesive system for rapid, inexpensive, and efficient vivarium management. The system will provide
substantial cost savings versus contracted cryopreservation services and increase the simplicity and reliability
of rat sperm cryopreservation procedures. RAIS will directly benefit the welfare of laboratory animals by reducing
the number of animals kept in idle colonies, improving vivarium management options, and protecting rat models
from catastrophic loss due to natural disasters, genetic drift, disease, and breeding problems. RAIS is designed
to provide both a reduction in animal numbers and a refinement to minimize animal suffering and improve
welfare, meeting the requirements of the 3Rs of animal research.

Public health relevance
Narrative Rodents are the most prevalent animals used for biomedical research and rat models are superior for use in toxicology, behavior, and physiology. This proposal is in direct response to the NIH funding opportunity announcement PAR-21-225 to develop novel tools and devices for animal research facilities and to support the care of animal models. ParaTechs proposes to develop and manufacture a rat artificial insemination system (RAIS), a complete rat sperm cryorecovery system, which will reduce the number of animals kept in idle colonies, improve vivarium management options, and protect animal models from catastrophic loss due to natural disasters, genetic drift, disease, and breeding problems.